Breaking barriers: Harnessing implementation mapping to promote caregiver coaching in early intervention

PROJECT SUMMARY
Critical to maximizing communication outcomes for children with developmental delays (DD) is access to a high
dosage of high-quality early intervention as early in development as possible. Children with DD under 3 years
of age qualify for early intervention (EI) services through publicly funded Part C programs under the Individuals
with Disabilities Act. A central tenet of Part C is that EI services should occur in the child’s natural environment
and include the family, rather than working exclusively with the child via therapist-delivered interventions. Such
interventions are often referred to as “caregiver-mediated interventions” (CMIs). Several meta-analyses suggest
that CMIs are effective for improving expressive and receptive language, social communication, and joint
engagement. Caregiver coaching is a critical element of CMIs, yet despite strong empirical evidence, fewer than
25% of families receive caregiver coaching. Identified barriers to the widespread use of caregiver coaching
include: (a) lack of training on caregiver coaching, (b) therapist and caregiver beliefs about their roles in early
intervention, and (c) therapist confidence, skill, and self-efficacy in using coaching practices. These barriers and
subsequent low rates of uptake highlight the disconnect between robust empirical support for caregiver
coaching and implementation. Such a disconnect requires developing and testing implementation strategies
that are tailored to address both: (a) the unique barriers to implementation in a given context (e.g., Illinois EI
system), and (b) various components of caregiver coaching (e.g., observation, feedback). As such, the
proposed study is guided by Implementation Mapping (IM), a 5-step participatory planning process to develop
and test strategies that promote the uptake of caregiver coaching. Each of our study aims corresponds to a
specific IM step and is informed by a specific implementation science framework. In Aim 1, we will select
implementation outcomes that are guided by Proctor’s taxonomy of implementation outcomes. In Aim 2, we will
use the Consolidated Framework for Implementation Research (CFIR) to characterize malleable factors that
influence implementation outcomes. Specifically, we will analyze qualitative data from focus groups using a rapid
deductive CFIR analysis approach. In Aim 3, we will integrate implementation outcomes with determinants to
create a working Implementation Research Logic Model that maps implementation strategies to specific
determinants. Potential implementation strategies will be selected using Expert Recommendations for
Implementing Change (ERIC) and will be reviewed by EI therapists (n=15) and caregivers (n=15) during two,
day-long, in-person workshops. In Aim 4, we will create the materials for the operationalized implementation
strategies from Aim 3. Even strategies selected from the ERIC list require tailoring to EI and caregiver coaching.
Implementation materials will be iteratively designed and refined using the Cognitive Walkthrough for
Implementation Strategies. Results of this project will yield a fully developed set of co-created implementation
strategies and materials that can be tested in a future hybrid Type 2 (effectiveness + implementation trial; R01).

Public health relevance
PROJECT NARRATIVE Critical to maximizing communication and other developmental, academic, and health outcomes for toddlers with developmental delays is access to high quality early intervention before 3 years, during a period of heightened neuroplasticity. Despite robust empirical support for the caregiver-mediated interventions, fewer than 25% of caregivers report being involved in their community-based early intervention sessions, highlighting the need to develop and test implementation strategies that will support the widespread use of caregiver coaching in Early Intervention. The proposed project is a qualitative early-stage implementation research study in which Implementation Mapping will yield an Implementation Research Logic Model and corresponding implementation materials that can be tested in a future Type 2 hybrid effectiveness-implementation trial (R01).